Developing and evaluating cell-specific lentivectors capable of selective in vivo generation of anti-HIV T cells to cure HIV

To enable sustained remission of HIV recurrence in the absence of antiretroviral therapy (ART), we aim to
develop a strategy to provide people with HIV (PWH) with robust and sustained anti-HIV T cell and antibody
responses. We will develop injectable cell-specific lentiviral vector (LV) technology to direct in vivo generation of
T cells expressing anti-HIV chimeric antigen receptor (CAR) and/or broadly neutralizing antibody (bNAb) genes.
We hypothesize that by establishing broad and sustained anti-HIV immune surveillance in vivo, reactivated
latently infected cells will be rapidly eliminated before they can initiate disseminated infection together with cells
newly infected by HIV produced by distal reservoirs. We developed and validated the safety and efficacy of a
highly potent and broad anti-HIV duoCAR-T cell therapy that is demonstrably superior to monoCAR-T cell
therapy. These duoCAR-T cells target two highly conserved independent gp120 epitopes, enabling highly
effective inhibition of HIV infection, while also being extremely resistant to HIV infection and providing sufficient
broad reactivity to inhibit the emergence of immune escape epitopes. Our preclinical studies demonstrating the
safety and efficacy of duoCAR-T cells and their great promise to provide PWH with sustained remission after
cessation of ART enabled FDA-approval, which has advanced them into clinical trials in PWH (NCT04648046).
We have also developed LV capable of engineering T cells to produce therapeutic levels of bNAb in vivo.
However, generating duoCAR-T cells or T cells secreting bNAbs using standard ex vivo LV transduction and
reinfusion into patients requires complex logistics which greatly limits wider use, particularly in resource-poor
settings with the highest incidence of HIV infection. This proposal is highly significant and very responsive to the
RFA, specifically our focus on developing and evaluating innovative approaches to engineer lentiviral vectors
(LV) to deliver in vivo T-cell targeted gene therapy to confer T cells with potent cellular and humoral anti-HIV
activity. We propose several innovative strategies to achieve our goal which include: (1) development and
optimization of novel CD3-targeted LVPs directing selective in vivo transduction of T cells to produce optimized
anti-HIV duoCAR-T cells; (2) identification of the CD3- or peptide-MHC conjugate-targeted LV most capable of
generating optimized anti-HIV duoCAR-T cells that potently suppress HIV infection in vitro and in vivo; and (3)
development and optimization of CD3-targeted LV to selectively transduce T cells in vivo to enable them to
produce bNAb. We hypothesize that administration of T cell-specific therapeutic LV will direct selective in vivo
generation of duoCAR-T cells and bNAb-producing T cells capable of exerting potent and sustained anti-HIV
immune surveillance, either alone or together, to provide PWH with ART-free remission. We will also examine
whether novel gp120-exosomes and multifunctional cytokine complexes consisting of IL-15 and a TGFβ inhibitor
or IL-7, IL-15 and IL-21 stimulate in vivo expansion of duoCAR-T cells to further augment their anti-HIV activity.

Public health relevance
Despite years of effective suppressive antiretroviral therapy (ART), latent HIV-infected cells can persist in people with HIV (PWH) and reintroduce disseminated HIV infection after cessation of ART, preventing the functional cure of PWH. The anti-HIV immune response in most PWH is inadequate to effectively eliminate reactivated latent infected cells, necessitating the development of strategies to boost the anti-HIV immune response to enable it to clear the reservoir after reactivation. We propose to develop cell-specific lentivector particles that can be injected into PWH to direct in vivo generation of T cells expressing anti-HIV therapeutic genes (CAR- chimeric antigen receptor and/or bNAb-broadly neutralizing antibodies, respectively) in PWH to provide them with sustained and robust anti-HIV CAR-T cell and antibody responses which will enable them to achieve sustained ART-free remission.